Functional Genomics Training Program (FGTP)

PROJECT SUMMARY
The goal of this new Functional Genomics Training Program (FGTP) is to provide
predoctoral students with an integrative training that encompasses basic research,
bioinformatics, clinical genetics, and ethics. Genomics has become the basis for the study
of human genetic disease, and we see a critical need for a formalized training program,
especially as interest in human genomics and precision medicine has grown and continues
to grow among students and the applicant pool at CWRU. Through this integrative model,
we aim to empower students with a specialized skillset critical for ushering in and shaping
the new era of precision medicine in both an efficient and responsible manner. To
accomplish this training goal, we assembled a well-funded cohesive group of mentors with
relevant genomics expertise in the following five key focus areas: (1) Mechanisms and
Treatment of Human Genetic Disease, (2) Chromatin, Regulatory Elements, and RNA, (3)
Bioinformatics and Biostatistics, (4) Cancer Genetics, (5) Clinical Genetics, Genetic
Counseling and Ethics. Training will include coursework and hands on training in functional
genomics and bioinformatics, along with clinically oriented training in which students
shadow clinicians, observe genetic counseling sessions, and follow clinical diagnostic
cases. Furthermore, as it is imperative to ensure that we train an ethically and socially
responsible next generation of biomedical scientists, our training model will also incorporate
ethics and the potential societal implications of functional genomics research, including
genome editing. CWRU, with two key Departments that recently procured large
reinvestments (Genetics and Genome Sciences, Population and Quantitative Health
Sciences), a Clinical Center for Human Genetics, a Genetic Counseling Program, Genetics
Diagnostic Labs, and two major hospitals (University Hospitals and the Cleveland Clinic), all
located within a 1 mile radius, provides an ideal training hub for our program. We believe
that this new program will have a significant and sustained impact on graduate education at
CWRU by serving as a vehicle for uniting functional genomics research across the
University and greater Northeast Ohio.

Public health relevance
PROJECT NARRATIVE This application proposes a new training program in Functional Genomics. Our program will provide predoctoral trainees with the conceptual and technical foundation for developing independent careers in basic and translational genetics and genomics. The training supports the overall mission of NIGMS to promote research that increases understanding of biological processes and lays the foundation for advances in disease diagnosis, treatment and prevention.